Investigating chromatin mechanisms using viral systems

PROJECT SUMMARY
(as stated in parent grant)
All eukaryotic genomes are compacted in a fundamental assembly called chromatin, the aberrant regulation of
which is a hallmark of many diseases and cancers. Technologies to study chromatin have advanced
significantly in recent years, allowing us to progress from linear sequencing to 3D chromosome conformation
studies. However, it is becoming increasingly clear that chromatin states are dynamic and respond to
perturbations. Thus a barrier remains to understanding the biological functions of chromatin in a dynamic
system, and not merely at the baseline state. Viruses have evolved to take over the cell to produce viral
progeny, necessarily hijacking cellular chromatin for viral benefit, thereby providing an ideal dynamic system in
which to interrogate chromatin state changes. Moreover, the study of virus-host interactions has been doubly
beneficial by leading to advances in virus biology and to discoveries of some of the most important areas of
molecular biology, from splicing to p53. Due to the advances in sequencing technology, we are now ideally
positioned to take the next step to understanding chromatin in the context of biological changes. In this
proposal, we aim to merge cutting-edge chromatin technology with virus infection to reveal
fundamental chromatin functions. We use two different nuclear replicating viruses, adenovirus and
herpesvirus, as the test cases for virus infection to pinpoint chromatin vulnerabilities exploited by multiple
pathogens. We have identified a viral packaging protein from adenovirus, protein VII, that causes global
chromatin reorganization and we will systematically dissect the mechanisms by which this reorganization
occurs. Our preliminary results suggest that protein VII, together with cellular binding partners, may replace
linker histones thus revealing a previously unknown vulnerability of chromatin. We have also uncovered that
herpes simplex virus incorporates the histone variant macroH2A1 on its genome during infection. MacroH2A1
has been described as a marker of both silencing and an activating chromatin, therefore, we will use this
scenario to untangle the long-standing enigma of macroH2A1 function. Completion of the proposed studies will
generate new chromatin targets and facilitate development of innovative therapies for cancer, inflammation,
and viral diseases.

Public health relevance
PROJECT NARRATIVE (as stated in parent grant) The cellular genome is compacted in a fundamental assembly called chromatin, the aberrant regulation of which is a hallmark of many diseases and cancers. Viruses have evolved to take over and exploit host cells, including cellular chromatin, to produce viral progeny. In this proposal, we will use nuclear- replicating viruses as a guide to pinpoint vulnerabilities of cellular chromatin with the goal of identifying new targets and facilitating development of innovative therapies for cancer, inflammation, and viral diseases.